Characterizing the feedback loop between cells and the pericellular region during cell-material interactions

Project summary
Interactions between human mesenchymal stem cells (hMSCs) and their environment are a main factor in the
function of these cells. Although the importance of cell-material interactions is well established, it has been difﬁ-
cult to characterize this complex interplay, especially in vivo. During in vivo experiments, a stem cell treatment's
efﬁcacy can be assessed, but the underlying cellular processes and change in the surrounding microenvironment
that leads to these outcomes remain a black box. Positive outcomes may result from these experiments even
if there is loss of function or integrity in the tissue due to failed cell-material interactions, making aspects of the
stem cell treatment ineffective and potentially unnecessary. Since real-time measurement of these interactions
has not been realized in vivo, in vitro models provide an alternative approach to measuring cell-material inter-
actions in both 2D and 3D culture. The use of scaffolds to mimic aspects of native tissue provide controlled
environments where cell-material interactions can be quantitatively characterized. These scaffolds are used for
3D cell encapsulation and are designed to be remodeled by cells. This creates a feedback loop where the cell
remodels the pericellular region and responds to the dynamically changing cues in the environment. Real-time
characterization of these dynamic cell-material interactions continues to be a challenge. We propose to char-
acterize dynamic cell-material interactions by measuring real-time hMSC-mediated scaffold remodeling using
microrheological characterization and the resulting cellular processes using cell staining and inhibition. We will
use an hMSC-laden synthetic hydrogel scaffold that mimics aspects of native microenvironments to present cues
to cells. To characterize hMSC function, we will use techniques including cell staining and pharmacological inhibi-
tion of molecules for cellular contractility and matrix adhesion. Our unique approach will characterize the scaffold
microenvironment in real-time during cell-material interactions. We will use multiple particle tracking microrhe-
ology (MPT) to measure hMSC-mediated scaffold remodeling and degradation. This technique quantiﬁes the
spatio-temporal evolution of the rheology in the pericellular region, which is part of the feedback loop that deﬁnes
cell-material interactions. Together, these measurements will provide a relationship between cellular function and
cell-engineered pericellular rheology as the complexity of the scaffold microenvironment is increased. The pro-
posed research program will focus on characterizing cell-material interactions during speciﬁc critical processes
that are not fully understood. The processes we will study are (1) cellular adhesion, (2) hMSC motility in re-
sponse to scaffold viscoelasticity and (3) hMSC-material interactions when signaling molecules are presented in
the environment. The proposed work will support the overarching goal of understanding the fundamentals of
cell-material interactions and the inﬂuence on basic cellular processes.

Public health relevance
Narrative Interactions between human mesenchymal stem cells (hMSCs) and their environment are a main factor in the function of these cells. During cell-material interactions, there is a feedback loop between environmental cues and hMSC-mediated remodeling of the pericellular region which is poorly understood. The proposed work will use synthetic hydrogel scaffolds to mimic aspects of the native tissue environment to quantitatively characterize the change in 3D encapsulated hMSC processes and dynamic hMSC-mediated pericellular degradation and remodeling to build a fundamental understanding of the role of cell-material interactions and the inﬂuence on basic cellular processes.